NATIONAL SLEEP RESEARCH RESOURCE (NSRR)

OBJECTIVES
The overarching goals of this resource contract are to 1) maintain the continuity and bioinformatic
serviceability of existing and new research data resources; 2) administer and service the resource
user community fostering optimal data-sharing, utilization, and scientific productivity; 3) and
develop the bioinformatic infrastructure, tools, and facilities enabling NSRR as an enclave of the
cloud-based NHLBI DataSTAGE program cloud users. Successful performance and meeting
requirements as an enclave of the NHLBI cloud-based DataSTAGE with platform integration and
acceptance of datasets under DataSTAGE is expected to establish a sustainable and scalable
path for future cloud-based sharing of sleep research datasets.